Host Immunity Against Bacteria

We are interested in how bacteria and bacterial products shape the development of subsequent innate and adaptive immune responses with the goal of understanding how these host-microbe interactions influence pathogenesis of infections, autoimmunity, allergy, and cancer. Our recently published work using a novel spore-based vaccine against a murine model of inhalation anthrax has shown that cholera toxin, a mucosal adjuvant and the agent responsible for the diarrhea caused by Vibrio cholera, induces a Th17 response characterized by CD4 T cells that secrete IL-17. In 2010, we have followed up on these studies by further investigating the effect of CT-induced gene products on Th17 regulation. These studies have resulted in insights into the regulation of Th17-related cytokines and their role in protection against infection with bacteria such as Staphylococcus aureus. In addition, we have investigated the effect of microbial exposure on the polarization of T cell differentiation. These studies enhance our understanding of the mechanisms controlling T cell differentiation and identify potential pathways that can be targeted to enhance efficacy of vaccines and therapies against cancer, infectious, and immune-mediated diseases.